Community Engagement & Dissemination Core

Community Engagement and Dissemination (CED) Core
Summary
There is a persistent and troubling gap between the knowledge generated by
health science research and its dissemination, translation and eventual uptake and use
by relevant stakeholders, including community members and professionals that
provide services to target communities. Closing this gap will be vital to reducing the
inequities in health and healthcare that unnecessarily shorten lives and reduce life quality in affected groups.
Historically-Black institutions (HBCUs) such as DSU, with their diverse faculty and student bodies,
importance in preparing African-Americans for careers in the health professions, and close ties to minority
communities can play a key role in the translation of research findings into sustainable community and
systems-level changes, which will mitigate, and ultimately prevent health inequities. Key to this translation
process is engagement with communities and effective dissemination of research findings, and involvement
of stakeholders, throughout the research lifecycle. The Community Engagement and Dissemination core of
the Interdisciplinary Health Equity Research Center (IHER) will facilitate collaborative relationships with
a wide array of Delaware-based stakeholders, allied in the shared goal of advancing the science of health
disparities, through a range of community-informed and community-engaged dissemination activities.
Our overall goal for the CED Core is to embed a Community First in All Research (CFiAR)
approach as a norm across the IHER Center to make research more impactful and responsive to community
needs and priorities. The CED core of our Center will be focused on: 1) Developing a Kent-Sussex County
Community Consultation Council and a network of community partners for research and dissemination; 2)
Working with our community partners to conduct a community level assessment of the needs of
underrepresented populations in Kent and Sussex Counties, as well as the existing resources, and services
that address those needs; 3) In collaboration with our community partners, develop dissemination strategies
and products, that will engage community members in health and health disparities research and science
activities. This will include developing a Dissemination Awards program for DSU and community-based
partners to facilitate contextually relevant dissemination activities and products to connect research findings
to target audiences and end users; 4) Facilitate, coordinate, and evaluate community engagement and
dissemination activities across all components of the IHER Center.
By implementing these activities, we expect to contribute to the overall goal of IHER of advancing
the science of reducing health inequalities by translating research findings into sustainable community and
systems-wide changes.